The Role of the RNA-binding Protein PABPC1 in Endothelial Gene Expression and Angiogenesis

Project Summary
Cardiovascular diseases are the primary cause of death around the world. Many such diseases involve a
restriction of blood flow to critical organs resulting in tissue death. There are also currently limited options for
treatment and there remains a significant need to discern the mechanisms of the angiogenic response.
Angiogenesis, the formation of new blood vessels from existing vasculature, involves intricate regulatory
mechanisms. RNA-binding proteins are among these regulators, yet their role in endothelial cells (ECs) and
angiogenesis remains poorly understood.
Using an in vitro loss-of-function screen, we identified the RNA binding protein Poly(A) binding protein
cytoplasmic 1 (PABPC1) as a key regulator of angiogenesis. We then generated EC-specific PABPC1 knockout
(iECKO) mice to study the role of PABPC1 in angiogenesis in vivo. We discovered reduced vascular progression
and increased immune cell infiltration during neonatal retinal angiogenesis of PABPC1 iECKO mice. Our
preliminary data suggest the roles of another RNA-binding protein ZFP36 and the chemoattractants CXCL1 & 8
in mediating observed phenotypes. It also suggests PABPC1 might regulate this process by binding to and
enabling the function of ZFP36. Hence, we hypothesize that endothelial PABPC1 regulates angiogenesis
through binding with ZFP36 to affect both mRNA stability of CXCL1 & 8 and immune cell infiltration.
To test our hypothesis, we will first determine in human cell culture models if PABPC1 suppresses CXCL1
or 8 mRNA in ECs by binding to the mRNA decay protein ZFP36 (Aim 1). We will also further characterize the
PABPC1iECKO retinal phenotype and determine if upregulated expression of the chemoattractant CXCL1
(mouse homolog of human CXCL1 & 8) mediates immune cell infiltration and reduced angiogenesis in
PABPC1iECKO mice (Aim 2).
The training in this proposal will focus on developing skills to produce a successful independent investigator
including project development, execution, and data analysis. New techniques will be learned and utilized during
this project including immunohistochemistry, cloning, and animal handling. Our lab has access to the vast
resources of the MCW Physiology department as well as experts in cardiovascular biology, gene expression
regulation, and RNA biology.

Public health relevance
Project Narrative This project studies a protein called PABPC1 which we believe controls blood vessel growth and inflammation. This protein has not been associated with these processes before, and we think this could provide new information that could lead to more treatment options for patients who need better blood flow such as in atherosclerosis or recovery after heart attack.